ACTG384--Protease inhibitor/reverse transcriptase inhibitor in initial HIV therap

To explore the metabolic function changes in subjects receiving dual nucleosides and either EFV or NFV or both for their primary HIV treatment.